A Real-time, Automated Maternal Hemorrhage Risk Assessment Platform Using Artificial Intelligence

Summary/Abstract
NOMA AI, Inc. is developing a real-time, automated, AI-led risk assessment software solution for
maternal hemorrhage. Maternal hemorrhage is a leading cause of maternal mortality and morbidity worldwide
and in the U.S. Significant disparities exist, with black mothers facing up to four times higher risk of mortality. In
addition to the risk of death, maternal hemorrhage can result in serious long-term complications; many patients
require blood transfusions and intensive care. Despite evidence that the majority (54-93%) of cases are
preventable, maternal hemorrhage and associated blood product needs have to-date proven exceedingly
difficult to predict. Thus, there remains a significant unmet care gap despite mandates and intense broad
efforts at improving preparedness and matching patients to risk-appropriate workflows.
Current strategies for managing maternal hemorrhage begin with separating patients into risk groups based on
specific known risk factors. This process is typically done manually using paper or electronic questionnaires,
defined by criteria developed by various consortia. However, these criteria lack both sensitivity and positive
predictive value: nearly half of mothers that require blood transfusion are categorized falsely as low risk. The
poor performance of existing tools suggests that critical risk factors and predictive features are not being
captured. NOMA AI proposes to solve this problem by leveraging state-of-the-art machine learning (ML)
techniques, as well as a much more comprehensive suite of risk factors, to develop improved and
dynamic risk assessment solutions that capture complex temporal patterns in patient conditions,
better informing doctors and reducing risk for mothers. In this Phase I effort, we will perform the first
comprehensive multi-center retrospective and prospective evaluation accounting for not only model
performance, but also fairness and bias of a complementary EHR-integrated clinical decision support software.
Our improved and dynamic risk stratification models will result in earlier recognition of risk and enable
proactive interventions, smarter allocation of resources, automation of tedious manual processes, reduced
blood transfusions and better patient outcomes. Our Aims are to 1) develop and evaluate improved maternal
hemorrhage risk assessment models using a suite of dynamic patient data and ML solutions, and 2) develop a
comprehensive bias mitigation/fairness pipeline for AI-led applications, which will help to address some of the
prevalent racial and ethnic disparities within maternal hemorrhage as well as serve future efforts to facilitate a
more equitable quality of care. This work will provide a foundation for a Phase II follow-on effort in which we
obtain key clinical feedback needed to develop our user interface and integrate it into clinical workflows, as well
as investigate critical milestones of real-time EHR integration and conduct prospective validation studies in
real-time, real-world clinical environments.

Public health relevance
Narrative Maternal hemorrhage is a leading cause of maternal mortality and morbidity in the U.S. Current maternal hemorrhage management protocols rely on patient risk assessment tools that lack the desired coverage and precision, resulting in a significant gap in care. NOMA AI, Inc. is developing real-time, automated patient monitoring technologies for dynamic stratification and assessment of the risk of maternal hemorrhage that seamlessly integrates into existing clinical workflows to provide the right level of care at the right time and improve patient outcomes.